"MEMORY" CD4+ T CELLS ARE RAPIDLY ELIMINATED IN SIV INFECTION IN VIVO

We have continued to examine the mucosal immunopathogenesis of SIV infection in the intestinal mucosa in order to determine why selective and profound CD4+ T cell depletion occurs specifically within mucosal tissues in early SIV infection To accomplish this, we have broadened our studies to extensively characterize the immunophenotype of the CD4+ T cells that are targeted in early SIV infection by four-color flow cytometry By examining uninfected normal rhesus macaques, we have shown that intestinal CD4+ T cells consist of a homogenous population of activated (CD69+CD38+HLA-DR+), memory (CD45RA-, L-selectin-), CD2+CD3+CD4+ T cells Since in vitro studies of both HIV and SIV have demonstrated that optimal viral replication occurs specifically within activated, memory CD4+ T cells, we hypothesized that the reason the intestinal cells are rapidly eliminated was that they are essentially all activated, memory cells To test this hypothesis, we followed acutely i nfec ted animals by four-color immunophenotyping of peripheral blood lymphocytes to determine whether a loss of this subset could be detected in other tissues Although activated, memory CD4+ T cells represent only a small proportion of peripheral blood lymphocytes, we could consistently find an early loss of this particular subset of CD4+ T cells could also be detected in the blood in relatively the same time frame as the intestinal CD4+ T cell depletion Combined, our data indicate that activated memory CD4+ T cells are the initial target for viral infection and amplification Future studies will explore the mechanisms by which these cells are depleted (apoptosis versus direct cell lysis, etc )